Toward field-ready paratransgenesis for malaria: bacterial strain optimization and microbiota interactions

PROJECT SUMMARY/ABSTRACT
Malaria is a disease caused by protozoan parasites (Plasmodium spp.) that are transmitted to humans by
female mosquitoes of the genus Anopheles. There are nearly 250 million new cases of malaria every year, and
over 600,000 people die from the disease while millions of others are severely debilitated (data from 2021).
About half of the human population is at risk of contracting malaria, and its range may spread as global
warming accelerates. A long-term research goal of high priority in the biomedical health sciences therefore is to
create new methods of combating malaria to complement current methods of control, namely insecticides to kill
mosquito vectors and drugs to kill parasites in infected people. The overall objective of this multi-PI proposal is
to engineer paratransgenic bacterial strains that can interfere with the ability of mosquitoes to transmit malaria
parasites. We will accomplish this by leveraging our combined expertise in bacterial genetics and vector
microbial ecology to overcome existing challenges that make currently available paratransgenic strains
unsuitable for field release. More specifically, we will engineer paratransgenic strains of Asaia bogorensis that
contain no antibiotic resistance genes, that are highly resistant against horizontal transfer to non-target
species, and that secrete combinations of effector proteins at sufficient quantities for optimal anti-Plasmodium
performance in vivo (Aim 1). We will also concurrently examine the impact of microbiota composition and
paratransgenesis system components on the overall fitness and anti-Plasmodium performance of
paratransgenic strains in mosquitoes colonized by bacterial communities derived from individuals collected in
malaria endemic regions of West Africa (Aim 2). Together, these experiments will allow us to identify field-ready
strains that are likely to persist after introduction into natural mosquito populations, with little to no impact on
resident microbial communities and minimal need for costly reintroduction strategies. They will also
significantly advance our fundamental understanding of how individual bacterial strains colonize and persist in
mosquito hosts–a topic of broad interest given the ability of mosquito-associated bacteria to shape mosquito
phenotypes important for pathogen transmission.

Public health relevance
PROJECT NARRATIVE Paratransgenesis (= the genetic modification of vector-associated microbes to produce and secrete anti- pathogen effector proteins) is a promising strategy for controlling vector-transmitted diseases like malaria, but current paratransgenesis platforms employ bacterial strains and/or plasmids that are not suitable for field release. Here, we will engineer paratransgenic strains of Asaia bogorensis that contain no antibiotic resistance genes, that are highly resistant against horizontal transfer to non-target species, and that secrete combinations of effector proteins at sufficient quantities to inhibit transmission of malaria parasites by mosquitoes. The genetic stability and persistence of paratransgenic strains in laboratory-reared mosquitoes colonized by field- derived microbiota will also be assessed, ensuring their capacity to spread in wild mosquito populations and therefore reduce malaria parasite transmission in the field.